Role of HSP70 in Pancreatic Diseases

Abstract
Several protective mechanisms have evolved to ensure survival of cells under adverse condition. `Heat
Shock Response' is one such survival mechanism. We have previously shown that heat shock protein-70, a
multi-faceted chaperone protein protects pancreatic acinar cells from damage during acute pancreatitis. We
have extended these observations to pancreatic cancer and have demonstrated that (HSP70) is
overexpressed in pancreatic cancer cells and plays a very prominent role in protecting cancer cells from cell
death.
While previous research focused primarily on the properties of the cancer cell, there has recently been
increased understanding of the role of the tumor microenvironment (TME) in supporting cancer growth.
Pancreatic cancer has an intricate TME, which is believed to contribute to its aggressive behavior. While
studies in non-pancreatic tumors suggest that lack of Heat Shock Factor-1 (HSF1) in stroma decreases the
growth of, the role of heat shock response pathway in shaping the TME of pancreatic cancer has never been
studied.
Intriguingly, our data suggest that triptolide, a natural heat shock inhibitor modulates pancreatic cancer
TME and depletes stroma. Our preliminary data also suggest that lack of HSP70 in stromal cells is
associated with increased cytotoxic T cell infiltration. Furthermore, we have shown that depletion of HSP70
in immune cells, the other important component of TME, decreases growth of tumors and that T cells lacking
HSP70 are more effective in killing pancreatic cancer cells in vitro. These data suggest that Heat Shock
Response/ HSP70 in various components of TME (immune vs stroma) influence tumor growth and that
triptolide could influence TME by modulating heat shock response.
The current grant is focused towards understanding the role of Heat shock response in biology of
pancreatic cancer. In specific aim 1 we will confirm the role of stromal HSP70 and Heat Shock Response
(HSR) in pancreatic cancer growth using a variety of animal models of pancreatic cancer as well as human
specimens. In aim 2, we will elucidate the mechanism by which HSP70 and heat shock response in tumor
stroma promotes tumor growth. Specifically, we will elucidate if lack of stromal HSR leads to increased
efficacy of immune cells against cancer cells. Finally, in aim 3, we will elucidate the mechanism(s) by which
HSP70 and HSR in immune cells promote pancreatic cancer growth. Specifically, we will evaluate whether
HSP70/HSR in T cells affect T cell activation and T cell mediated killing. We believe that elucidation of the
mechanism by which HSP70/HSR in TME modulate pancreatic cancer progression will lead to increased
comprehension of the mechanism cancer cell uses to evade cell death.

Public health relevance
Narrative We have previously shown that HSP-70, a chaperone protein, protects pancreatic acinar cells from damage during acute pancreatitis. We have extended these observations to demonstrate that HSP70 is overexpressed in pancreatic cancer cells and plays a very prominent role in protecting cancer cells from cell death. While previous research focused primarily on the properties of the cancer cell, there has recently been increased understanding of the role of the tumor microenvironment (TME) in supporting cancer growth. Current grant is focused on understanding the role of HSP70 in TME on Pancreatic cancer progression.